“NCI National Clinical Trials Network - Network Lead Academic Participating Sites”

Abstract
Norris Cotton Cancer Center (NCCC), the keystone of the cancer-related activities of both Dartmouth College,
including its Geisel School of Medicine, and Dartmouth-Hitchcock Health, will participate in the NCI's National
Clinical Trials Network as a Lead Academic Participating Site. NCCC has a long history of leadership in
national cooperative group clinical trials, dating back to serving as an operating center for CALGB, and more
recently as a main member of the Alliance for Clinical Trial in Oncology, NRG, COG, and ECOG/ACRIN. As
the only NCI designated Comprehensive Cancer Center in northern New England, NCCC currently serves
annually over 5,000 new patients and 30,000 returning cancer patients. NCCC is the specialty academic center
for Vermont and New Hampshire, anchoring a network of 17 community-based practice sites across the region
and receiving referrals of rare and advanced cancers, the target population for enrollment on innovative clinical
trials, from a large geographic catchment area. Within Dartmouth, NCCC has a central Office of Clinical
Research (OCR) which coordinates full participation in the entire range of available clinical trials. NCCC
intends to participate fully in all NCTN activities, expanding its prior focus on participation in the Alliance.
NCCC investigators are active in many NCTN Operations Center committees, facilitating a bi-directional
integration of NCCC concepts into the NCTN, while NCTN studies will be seamless incorporated into the
NCCC trial portfolio. We anticipate accrual of 55 consented subjects on high performance intervention for
treatment trials and 20 subjects on screening only accruals for treatment or imaging trials. Care at DH is
organized into 17 designated interdisciplinary disease-based teams which bring together all relevant
specialties, 14 on a weekly basis, for new patient conferences at which eligibility for enrollment on clinical trials
is assessed routinely. NCCC research nurses assigned to these Clinical Oncology Groups (COGs) are
responsible for keeping the teams informed of available trials, and the NCCC clinical trials management
system (Velos eResearch) provides the teams reports tracking current enrollment. While highest priority is
given to translating NCCC science into clinical application, Dartmouth's size precludes most single-institution
studies, and national cooperative group trials are prioritized ahead of industry-initiated studies for fulfillment of
NCCC's clinical research mission.

Public health relevance
Project Narrative Dartmouth-Hitchcock Health is the leading specialty care network for a vast geographic region covering New Hampshire and Vermont statewide. The Norris Cotton Cancer Center (NCCC) is the academic hub for services for rare and advanced cancer cases across the region. As a Lead Academic Participating Site in the National Cancer Institute’s National Clinical Trials Network, our overarching mission is to advance the NCTN collaborative clinical research program of definitive clinical trials, including multi-modality, umbrella/basket, and rare tumor trials, and to translate basic science studies into meaningful advancements in the care of Northern New England cancer patients.